Regulation of Skeletal Muscle LKB1

DESCRIPTION (provided by applicant): LKB1 was reported in September 2003 to be a component of the AMP-activated protein kinase (AMPKK) activity in extracts of liver and of cells in culture. AMPKK phosphorylates and activates AMPK which then phosphorylates proteins involved in stimulation of fatty acid oxidation, stimulation of glucose uptake, increasing insulin sensitivity and in controlling content of hexokinase, GLUT4, and mitochondria! oxidative enzymes in skeletal muscle. AMPKK and AMPK are activated in muscle in response to muscle contraction. Because of the well-demonstrated effects of AMPK activation on glucose uptake, fatty acid oxidation, GLUT4 expression, and insulin sensitivity, this signaling system has been targeted for development of Pharmaceuticals for prevention and treatment of type 2 diabetes. We have recently developed a muscle specific LKB1 knockout mouse in our laboratory that will enable elucidation of roles and mechanisms of activation and actions of the tumor suppressor protein, LKB1, in skeletal muscle. More specifically, these experiments will verify that LKB1 is a component of the AMPKK complex in skeletal muscle and provide new information regarding its regulation. The specific proteins associating with LKB1 in resting and contracting muscle to produce AMPKK activity will be determined. Using recombinant proteins expressed in mammalian cells we will determine which components of the LKB1 complex (postulated to be LKB1, STRAD, MO25 and HSP90) are essential for AMPKK activity. The mechanisms of activation of LKB1 in muscle will be investigated. Finally, the mechanisms of enhancement of GLUT4 transcription by LKB1 and AMPK in skeletal muscle will be studied. This information will be crucial for design of Pharmaceuticals targeting this pathway for treatment of type 2 diabetes. The proposed studies will provide additional rationale for convincing a predominantly sedentary population of the importance of regular exercise in combating inactivity-related diseases.